Leveraging Causal Inference and Machine Learning Methods to Advance Evidence-Based Maternal Care and Improve Newborn Health Outcomes

PROJECT SUMMARY/ABSTRACT
The United States (U.S.) trails behind almost all high-income nations with respect to newborn health, with rates
of adverse outcomes, including perinatal mortality, preterm birth, and low birthweight, having demonstrated
minimal progress in recent years. Significant disparities underlie such outcomes, with higher rates among
racial and ethnic minorities and individuals of low socioeconomic status. While such populations frequently
face barriers in accessing adequate care, other studies suggest that certain low-risk populations experience
over-provision of maternal care. Rising trends in prenatal care and imaging, for example, are tempered by
limited rigorous evidence that increases in utilization have meaningfully improved outcomes. This reality
necessitates a renewed approach to maternity care, including: 1) generation of evidence-based policies and
guidelines, particularly ones that benefit vulnerable populations; and 2) better assessment of interventions with
ambiguous benefit to improve targeting of care. Two specific areas of policy and clinical relevance include
access to immediate postpartum contraception and antepartum fetal surveillance, strategies with potential to
improve newborn outcomes but for which existing evidence is limited. Accordingly, the overall goal of this
proposal is to produce rigorous evidence on: 1) a Medicaid policy incentivizing provision of immediate
postpartum long-acting reversible contraception (IPP-LARC); and 2) the scope and effect of
antepartum fetal surveillance. Aim 1 utilizes state inpatient discharge data from three states and a synthetic
control design to estimate the impact of Medicaid provider payments for provision of IPP-LARC on short birth
intervals, preterm birth, and low birthweight. Aim 2 leverages electronic health record data from a large,
integrated health system and a machine-learning-based propensity score design to assess the scope and
effect of antepartum fetal surveillance on perinatal mortality and other related newborn outcomes. The
proposed research aligns closely with the National Institute of Child Health and Human Development’s
(NICHD) research priorities to promote reproductive health, better understand the health impacts of
contraception, empower healthy pregnancies, and address health disparities. The overall fellowship training
plan will be supported by a multidisciplinary mentorship team and a collaborative training environment
dedicated to research, professional, and clinical skills development. Through bridging methods in machine
learning and quasi-experimental evaluation that have rarely been used in the evaluation of maternal care
policies and guidelines, this proposal will be instrumental in informing data-driven clinical practice around
immediate postpartum contraception and antepartum fetal surveillance. Together, such evidence will help
advance equitable newborn outcomes in the U.S.

Public health relevance
PROJECT NARRATIVE In light of unsettlingly high rates of adverse newborn outcomes – such as perinatal mortality, low birthweight, and preterm birth – in the United States, evidence-based approaches to improve maternity care are vital. Medicaid provider incentives for provision of immediate postpartum long-acting reversible contraception and antepartum fetal surveillance offer two potential strategies to enhance outcomes via improvements in birth spacing and early detection of fetal distress, respectively. In the absence of a robust evidence base, the proposed research will rigorously estimate the impact of each strategy on newborn outcomes to inform data- driven clinical practice around postpartum contraception and antepartum surveillance.